A novel therapeutic approach for Alzheimer Disease (AD)

Project Summary
Alzheimer's Disease (AD) is a chronic neurological disorder causing cellular and organismal metabolic
dysfunction, progressive memory decline and cognitive impairments. Nicotinamide adenine dinucleotide (NAD+)
is an essential metabolite that is involved in cellular bioenergetics, genomic stability, mitochondrial homeostasis,
adaptive stress responses, and cell survival. A growing body of evidence indicates that NAD+ decline is
accompanied with progression of AD. In mammalian cells, the salvage pathway of NAD+ biosynthesis is the
predominant pathway for NAD+ biosynthesis, where nicotinamide phosphoribosyltransferase (Nampt) is the rate-
limiting enzyme. Thus, physiological means to systematically maintain elevated NAD+ levels to augment cellular
metabolic activity in the brain may represent an efficient anti-AD intervention. Red blood cells (RBCs),
differentiated from hematopoietic stem/progenitor cells (HSPCs) in bone marrow (BM) and release to blood
circulation system after maturation, are the most abundant cell type in whole body, and thus, increase in NAD+
synthesis in these cells using genetic interventions may provide a physiological means for systematic and
sustained elevation of NAD+ in whole body through the circulation system. Here we developed an innovative
approach, i.e., using serotype helper-dependent adenovirus (HD-Ad5) to overexpress NAMPT in the RBCs
following in vivo transduction of autologous HSPCs in mouse model. We hypothesize that Nampt
overexpression (OE) in RBCs provides systematic and sustained NAD+ production to increase metabolic activity,
and counteract NAD+ decline in AD and ameliorate AD conditions. To test our hypothesis, we propose the
following two specific aims. Aim 1 will test that Nampt OE in RBCs can systematically elevates NAD+ levels in
metabolically active organs and enhances metabolic activity at cellular and organismal levels. We will transduce
HSPCs by HD-Ad5-Nampt vectors containing Nampt gene to overexpress Nampt in RBCs and subsequently
examine the NAD+ levels and metabolism in the brain and whole animal over a long-term period. Aim 2 will test
that Nampt OE in RBCs can counteract NAD+ decline and alleviate AD pathologies in APP/PS1 AD mouse model.
Using different methods, we will determine the effect of Nampt OE in RBCs on neuronal degeneration, Amyloid
β (Aβ) burden, adult neurogenesis, cognitive decline, and dementia in AD mouse model. This application is
highly innovative in concept, hypothesis and approach. Targeting RBCs using genetic approach for the therapy
of genetic diseases here AD other than in the blood system may change gene therapy paradigm and represents
a novel therapeutic strategy. Our project is highly feasible based on our preliminary data, thus, has both scientific
and translational significances for AD and other brain diseases.

Public health relevance
Project Narrative Alzheimer's disease (AD) is the most common cause of cognitive decline and dementia. The proposed project will develop a novel genetic approach for AD therapy by expressing NAMPT, a rate limiting enzyme in NAD+ salvage pathway, in red blood cells (RBCs). Targeting RBCs for AD therapy represents an innovative strategy for AD therapy that could delay or reverse the development of AD pathologies and thus has both scientific and translational significances.